Fatty acid signaling in distinct taste cell types

PROJECT SUMMARY
Recent data has shown that individual taste modalities may not be completely segregated with specific
cell types in the taste bud which has begun to question the strict roles previously attributed to the various subsets
of cells within the mammalian taste bud. Using fatty acid taste as a model, where both Type II and Type III cells
have been implicated in in fatty acid signaling, we will attempt to generate the data necessary in this exploratory
research program to be able to tackle larger questions surrounding the cell type function within the taste bud. To
accomplish this, however, requires we have a thorough understanding of the cellular and molecular
underpinnings of fatty acid transduction in Type II and III cells. Moreover, given the emerging data that shows
pronounced sex differences in fatty acid taste signaling and its regulation, this project includes a careful analysis
of signaling in males and females (at various stages) using a cell-based approach. Specifically, we will test the
hypothesis that Type II and Type III cells both respond to fatty acids but do so via different transduction pathways
that may ultimately reflect a different role in these cell types.
Our goal is to elucidate the transduction pathways for two classes of fatty acids in the mammalian taste
system in Type II and Type III cells and identify any potential sex differences in these pathways. The two-year
R21 mechanisms is ideally suited to accomplish these important goals in a timely fashion. Once armed with
these data on the mechanics of signaling for long chain unsaturated fatty acids (lcUFAs) and medium chain
saturated fatty acids (mcSFAs) in Type II and III from males and females, it will be possible to directly assess
the role of these cell types in signal processing within the taste bud. For example, our working view on the
function of these cell types is that Type II cells are involved most directly in the initial signal transduction for fatty
acids while Type III cells perform a more modulatory role in response to changes associated with dietary
experience and/or disease (obesity; diabetes). To test this will require identification of important targets within
these pathways so that experiments like cell type specific manipulation of gene expression can tease apart the
functional differences. To generate the necessary information, we will use patch clamp recording and functional
calcium imaging in association with pharmacological interventions and ion substitution to elucidate the
transduction pathway for these two classes of fatty acids in genetically identified Type II and Type III cells. To
address the sex specificity within these pathways, we will compare males, females in proestrus, females in estrus,
and ovariectomized (OVX) females with and without hormone replacement to address two specific aims:
• To elucidate long chain unsaturated fatty acid transduction in Type II and Type III cells (Aim 1)
• To explore the signaling elements in GPR84 transduction pathway in taste cells (Aim 2)
This will provide the necessary background data to allow more detailed exploration of the role of fat taste
in the peripheral gustatory system and its regulation by the endocrine system due to effects of diet and disease.

Public health relevance
NARRATIVE There are two primary objectives in the current proposal that remain key to understanding peripheral fatty acid signaling in the taste system and, in general, the roles of various taste cell types. The first deals with the mechanistic underpinnings of Type II and Type III cells in the transduction of two classes of fatty acids – the long chain polyunsaturated fatty acids and the medium chain saturated fatty acids. The second expands from earlier research showing pronounced sex differences in fatty acid signaling and fat taste and attempts to use cell-based assays to explore the details of these differences within these cell types.